Longitudinal neuronal and behavioral responses to microstimulation of LGN by ultraflexible electrodes

Project summary
Approximately 40 million people across the world suffer from blindness, a condition severely impacting their
autonomy and quality of life. Restoration of visual function in these blind individuals is an important scientific goal
with large societal benefits. Current visual prosthetic devices interface with the visual pathways at the retina or
the visual cortex. Retinal prostheses are relatively safe to implant but are not applicable for most blind patients
who have severe eye damage causing a disconnection with the brain. Cortical prostheses could open treatments
to a much wider range of diseases and patients, but making such devices applicable to human patients faces
significant challenges, particularly in the lack of sufficient visual field coverage and lack of tissue compatibility for
long-term implantation. To overcome these limitations, this bioengineering research grant proposes a unique
approach for visual prostheses, using large-scale, tissue-integrated, ultraflexible electrodes to interface with the
lateral geniculus nucleus (LGN), the relay station between the retina and the visual cortex. The objective of this
project is to establish the feasibility and acquire the key knowledge to build a lasting LGN visual prosthesis with
an unprecedented visual coverage able to elicit pattern perception. To achieve this goal, we will use
NanoElectronic Threads (NETs), currently the thinnest, most flexible, least tissue-invasive indwelling electrodes
for stable, long-lasting microstimulation in the LGN. We will implant a large array of 500 – 1000 channels in the
relatively small volume of LGN in NHP to attain sufficient coverage of the visual field and resolution of artificial
vision. Aim 1 will examine the perceptual properties of phosphenes elicited by microstimulation of LGN in NHP,
for which we will determine the receptive field and visual field coverage and establish shape perception. Aim 2
will elucidate neural responses and downstream signaling of LGN stimulation in mice. We will determine the
longitudinal stability of LGN and V1 activation as well as the stability of RFs of stimulated LGN neurons in both
normal seeing and blind animals. Aim 3 will optimize and determine the long-term stability of phosphene
detection in NHP. We will evaluate and optimize charge injection capacity of NETs in vitro and determine the
stability of perception in NHP for two years. The project will drive both scientific advancements in visual system
neuroscience and technological innovation of flexible prostheses engineering, paving the way for a revolutionary,
high-resolution visual prosthesis that can offer unprecedented levels of sight restoration and transform the lives
of millions of people suffering from blindness.

Public health relevance
PROJECT NARRATIVE: Large-scale electrical interfacing with LGN for visual prostheses have the potential to restore visual function to millions of people worldwide suffering from blindness but have not been realized. This project will establish feasibility and acquire the key knowledge to build a high-channel-count, long-lasting, high-resolution, LGN visual prosthesis. Its success could revolutionize the treatment of visual impairments and offer unprecedented levels of sight restoration, addressing a critical public health issue.